Leveraging Electronic Health Records and artificial IntelligeNce to improve Dementia Screening and early Detection in primary care (LEARN-DSD)

Project Summary/Abstract:
Alzheimer’s Disease and Alzheimer's Disease related dementias (AD/ADRD) are irreversible conditions affecting
over 6 million people in the United States. While the pathogenesis of AD/ADRD is complex, modifiable
cardiovascular risk factors contribute to its pathogenesis. These risk factors are unequally distributed, with higher
prevalence among socioeconomically disadvantaged and racial and ethnic minority groups, and the problem is
compounded by lower rates of cognitive screening and diagnosis across these groups – as documented in Black,
Latino, Asian, and Native American populations. While referral to qualified memory specialists (geriatricians
and/or neurologists) for evaluation and management is considered gold standard, in practice most diagnosis and
management of AD/ADRD occurs in non-specialty (primary care) settings, due to shortage of specialists. Novel
cognitive screening programs that leverage electronic health records (EHRs) have the potential to close this gap
considerably. In this context, we propose a multicomponent stakeholder- and technology-based framework to
improve early detection of MCI and AD/ADRD, to elevate the quality of cognitive screening and secondary
prevention within primary care, with a focus on practices that treat patients from socioeconomically and racially
diverse backgrounds. We will design and implement an embedded Pragmatic Clinical Trial (ePCT) that involves
engaging patients, families and PCPs to refine existing practices on how PCPs should present information on
cognitive screening, MCI and AD/ADRD diagnosis, and their linkage with cardiovascular disease. We will
leverage an EHR-based clinical decision support tool based on retrospectively validated artificial intelligence (AI)
and machine learning (ML) methods for identifying MCI and AD/ADRD. Primary outcome for the ePCT will be
the rate of cognitive screening, and secondary outcomes will include diagnosis of dementia, and secondary
cardiovascular preventive measures. This ePCT effort will focus on the two NYU Langone Health Brooklyn
ambulatory care centers, which include over 70 PCPs and over 10,000 patients age ≥65 years. (With 62% self-
identified as non-white). Our Specific Aims are to (Aim 1) Conduct a pilot ePCT to optimize and evaluate the
acceptability, usability and adoption of implementing an existing AI/ML tool and PCP decision support in a
predominantly racial and ethnic underrepresented minority cohort. (Aim 2) Validate and monitor the ePCT
primary outcome of cognitive screening, and secondary outcomes of diagnosis of MCI, AD/ADRD, and
cardiovascular disease prevention outcomes. (Aim 3) Perform a sub-analysis of patient outcomes across
different racial/ethnic subgroups for differences in uptake of screening, diagnosis, secondary cardiovascular
preventative interventions. This pilot ePCT will pave the way for larger scale pragmatic trials that will address an
unmet and urgent need in cognitive health management of elderly population, particularly those most vulnerable
to the disease.

Public health relevance
Project Narrative This grant will design and measure a novel stakeholder- and technology-based framework aimed at improving dementia screening and diagnosis, secondary cardiovascular preventive measures, and utilization of anticholinergics, in primary care settings, and among disadvantaged and racial and ethnic minority populations at risk for dementia. The study will be in the context of a pilot Embedded Pragmatic Clinical Trial (ePCT) that is optimized with/for the stakeholders (patients, caregivers, primary care providers) and leverages validated methods based on electronic health records, artificial intelligence, and modern clinical workflow integration. This pilot ePCT will pave way for larger ePCTs that address disparities in timely diagnosis, access to specialists, and evidence-based care delivery.